Antiretroviral Treatment Interruption as a Long-term Therapeutic Strategy

Although combination antiretroviral therapy (ART) has been successful in suppressing plasma HIV RNA levels in infected patients, it has not resulted in eradication of virus. Prolonged, continuous ART results in significant toxicities and difficulties adhering to drug regimens. In addition, the cost of antiretroviral drugs is prohibitive for many individuals and countries. Therefore, we have studied the virologic and immunologic effects of intermittent versus continuous ART in HIV-infected individuals in an attempt to reduce the total time an individual receives therapy while maintaining therapeutic efficacy. To test the need for and feasibility of strict adherence to a short-cycle intermittent ART regimen, we are currently conducting a randomized, controlled trial of short cycle (5 days on, 2 days off) intermittent therapy versus continuous ART in Kampala, Uganda (Protocol 02-I-N288, A Randomized, Controlled Trial of Short Cycle Intermittent versus Continuous HAART for the Treatment of Chronic HIV Infection in Uganda). The study originally included a 7/7 arm (7 days on, 7 days off) but was discontinued because several patients failed specific study criteria. Patients initially enrolled in the 7/7 arm were transferred to continuous therapy and are being monitored for the original duration of the study (73 weeks). The study enrollment and follow-up have been completed with 146 patients total;32 in the 7/7 arm, 57 in the 5/2 arm and 57 in the continuous arm. The main primary outcome analysis was published in PLOS One in April 2010. The antiretroviral resistance data was published in Antiviral Therapy and is included in the bibliography below. Baseline characteristics were similar between study arms. Following enrollment of 32 participants, the 7 days on/7 days off arm was closed because of a failure rate of 31%. Six of 52 (11.5%) participants in the 5 days on/2 days off arm failed. Five had virologic failure and one participant had immunologic failure. Eleven of 51 (21.6%) participants in the continuous treatment arm failed. Nine had virologic failure with 1 death (lactic acidosis) and 1 clinical failure (extra-pulmonary TB). The upper 97.5% confidence boundary for the difference between the percent of non-failures in the 5 days on/2 days off arm (88.5% non-failure) compared to continuous treatment (78.4% non failure) was 4.8% which is well within the preset non-inferiority margin of 15%. No significant difference was found in time to failure in the 2 study arms (p=0.39). In summary, short cycle intermittent ART may be an important option for the treatment of HIV infection to reduce cost and, possibly, toxicity while potentially enhancing adherence. If safety and efficacy of short-cycle intermittent therapy is ultimately demonstrated in other clinical settings, it might prove to be an important strategy to expand therapy in resource-limited settings.